Regulation of nociceptor excitability by macrophage migration inhibitory factor (MIF) as a therapeutic strategy for chronic pain treatment after spinal cord injury

Project summary
Affecting over half of people living with spinal cord injury (SCI), chronic neuropathic pain can have a disastrous
impact on quality of life. Despite recent advances in understanding neuropathic pain, its mechanisms remain
elusive and it is still largely resistant to available treatments, including opioids. Increasing evidence indicates
that mechanisms important for chronic SCI pain are located within the cell bodies of nociceptive sensory
neurons and their sensory terminals. After moderate contusive injury at the thoracic level in rodents, a
nociceptor hyperactive state exhibiting ongoing, apparently spontaneous, firing of action potentials can drive
chronic pain. Dorsal root ganglia (DRGs) receive circulating influences from the blood and cerebrospinal fluid
due to DRGs’ rich vascularization, lack of an effective vascular permeability barrier, and intrathecal location.
Thus, circulating factors (e.g., hormones, cytokines) and their downstream signaling pathways that drive
nociceptor hyperactivity may be logical therapeutic targets for relieving SCI pain. We recently showed that
macrophage migration inhibitory factor (MIF), a key pro-inflammatory cytokine that has been understudied in
preclinical models of inflammatory and neuropathic pain, induces a hyperactive state in dissociated nociceptor
cell bodies comparable to that produced by SCI. MIF is effective when delivered at concentrations reported
acutely and chronically in the plasma of SCI patients. Nociceptors from SCI rats exhibit a higher sensitivity to
MIF, a MIF inhibitor suppresses this hyperactive state in vitro, and injections of MIF in naïve rats trigger an
affective pain state assessed by operant behavioral tests. Preliminary findings reveal that i) CXCR2 receptors
contribution to MIF hyperexcitability, ii) isolated human nociceptors are hyperexcitable upon MIF treatment,
and iii) nociceptors from naïve rats show hyperexcitability when exposed to plasma from SCI rats, providing
direct evidence for circulating excitatory factors released after injury. This multidisciplinary and highly
collaborative project will define the contribution of MIF and its downstream signaling to SCI-induced
neuropathic pain. The guiding hypothesis is that after SCI, MIF stimulates a nociceptor hyperactive state in a
CXCR2/CXCR4-dependent manner, and that pharmacological inhibition of MIF and/or its receptors will
alleviate chronic ongoing pain by reducing nociceptor hyperactivity. This hypothesis will be tested using
nociceptors from rodents and humans. Aim 1 will determine the MIF signaling driving the nociceptor
hyperactive state. Aim 2 will test the prediction that inhibition of MIF and/or its signaling can reduce chronic
pain behavior after SCI. Aim 3 will validate MIF and/or its signaling as a promising therapeutic target by
characterizing the effects of MIF and its signaling on isolated human nociceptors. A novel in vitro
electrophysiological assay using rodent nociceptors will be used to test plasma from SCI patients for
contributions of increased circulating MIF to nociceptor hyperactivity, and potentially for many other circulating
factors helping to drive chronic pain.

Public health relevance
Project narrative: Chronic pain afflicts over 1 in 5 adults in the US, reduces quality of life, and leads to economic burden. Despite extensive research, the mechanisms causing chronic pain remain poorly understood, and treatments are inadequate, emphasizing the need to identify better therapeutic targets. This multidisciplinary project will focus on a promising contributor, macrophage migration inhibitory factor (MIF), for which we have recently demonstrated persistent roles in pain-related nociceptor hyperactivity after spinal cord injury (SCI).